Development of inhibitors to selectively target the CBX8 chromatin reader domain

Project Summary
The mis-regulation of chromatin drives both cancer progression and chemotherapy resistance. For example,
alterations in the trimethylation of histone 3 at lysine 27 (H3K27me3) is associated with numerous cancers;
however, H3K27me3 is also important in numerous normal cellular processes as well. H3K27me3 marks are
targeted by the chromodomains of the chromobox (CBX) subunits of Polycomb Repressive Complex 1 (PRC1),
which compacts chromatin and represses transcription. There are five CBX paralogs (CBX2,4,6,7,8) that have
differential expression in cancer. While CBX6 and CBX7 are often decreased in cancer, CBX2 and CBX8 are
frequently increased in cancers. Chromodomains for several CBX paralogs (CBX4, 6, 7) have been successfully
targeted with small molecules and peptides that display moderate potency and selectivity. To develop CBX2 and
CBX8-selective inhibitors, our research team developed a robust and sensitive assay for affinity-based
enrichment of ligands from DNA-encoded libraries and utilized these assays for selections of focused DNA-
encoded libraries against a panel of chromodomains. The selective CBX8 inhibitors developed using this
approach have validated the CBX8 chromodomain as a therapeutic target in MLL-AF9 leukemia; however, their
low cell permeability limits their utility in targeting CBX8-specific function in these cancers. In this grant, we will
develop improved CBX8 inhibitors using DNA-encoded libraries selected and designed for increased cellular
activity compared to current probes. Hit molecules will be resynthesized off-DNA and tested for affinity and
specificity in vitro, as well as in cells. Cellularly active CBX8 chromodomain inhibitors will be used to validate the
selective inhibition of CBX8 as a viable, non-toxic therapeutic strategy in vivo.

Public health relevance
Project Narrative The five paralogous CBX proteins are the histone targeting subunits of Polycomb complexes, which control the compaction of DNA in the nucleus of a cell. Polycomb complexes play a critical role in promoting human tumor oncogenesis and chemotherapy resistance. Selective inhibitors of individual CBX paralogs will lead to new biological understanding of their role in cancer and new possibilities for less toxic cancer treatments. 1